Implicit Bias in the Evidence: An Evaluation of Female-Predominant Disease

This research explores the use of heuristics in diagnostic decision making for conditions that do not have
definitive diagnostic tests and rely on a set of diagnostic criteria. Because clinicians are Bayesian by nature,
cognitive heuristics are used to estimate the probability of a given condition based on the representativeness of
that case among “the average” in diagnostic decision making. Over time, reliance on these shortcuts influences
how patients are diagnosed, and in turn, these patients add to the growing evidence base. This may lead to a
multi-state confirmation bias in the practice of evidence-based medicine. Our first step to evaluate this complex
cycle is to question how the evidence and deviations from the norm influence what diagnosis a clinician gives.
We ask: Does the diagnosis a patient receives vary when all that differs is their sex, gender, or race? Our initial
pilot shows that clinicians make more diagnostic errors when presented with patients of sex/gender/race that is
less common, despite identical clinical signs and symptoms of lupus. We will extend on our experimental
approach evaluating implicit bias in the diagnosis of lupus, which builds off of research on discrimination in
hiring. This work specifically asks whether when the disease presents the same, does a patient deviating from
the “norm” based on the evidence, influence the diagnosis? We will consider additional female-predominant
diseases and determine whether a physician's diagnosis is influenced by a patient's sex/gender/race holding
everything else constant. First, we will conduct a national internet-based randomized experiment among
specialists to assess the role of sex/gender/race in the clinical workup and its contribution to observed
heterogeneity and disparities. Second, we will conduct additional randomized experiments in primary care to
determine how sex/gender/race influences their clinical workup and referral patterns. Third, we will use mixed
methods to characterize and improve our understanding of how clinicians approach diagnostic questions, and
identify non-biological, potentially modifiable factors contributing to health disparities. We will conduct focus
groups with providers using experimental results as discussion prompts to contextualize findings and inform
strategies to address this type of multi-state confirmation bias. This innovative work adapts a novel method by
combining methods from sociology, experimental design, and behavioral science. Our findings will increase
clinicians' awareness of how cognitive biases that may lead to medical errors, and will demonstrate how an
incomplete evidence base may propagate health disparities leading to delayed diagnosis, worsening disease,
and irreversible damage.

Public health relevance
This innovative work evaluates how over-reliance of the evidence base and potential implicit bias may perpetuate diagnostic delay and poorer management for subsets of patients via a multi-state confirmation bias, consequently increasing risks and costs. Using a series of randomized experiments and mixed methods, we will evaluate this proposed bias in clinical decision-making and work with physicians across multiple specialties to potential targets to reduce diagnostic delay. This work will challenge existing paradigms, not only for the diseases evaluated, but more broadly increase awareness about how implicit bias may impact clinical decision making in complex female-predominant diseases such as systemic lupus, multiple sclerosis, and Grave's disease.